Dialysis Access Justice, Equity, Diversity, Inclusion (DA-JEDI) Program.

ABSTRACT
ASN is the largest nephrology society in the world with more than 21,000 members and a longstanding
commitment to justice, equity, diversity, and inclusion. Within kidney disease there is a great need for equity in
dialysis access (DA). We plan to significantly expand our DEI footprint in this area through the Dialysis Access-
Justice, Equity, Diversity and Inclusion program (DA-JEDI) by recruiting a cohort of fellows/early-career faculty
who identify as underrepresented in medicine (URM). These individuals would then be exposed to a unique
blend of mentorship, leadership, and skill development courses, with a strong DA focus, that will set them on a
pathway to become champions for equitable, patient-centered DA care, and also future leaders in ASN and the
broader dialysis access and kidney community. We will achieve these goals through four specific aims.
In Specific Aim 1 we will recruit a cohort of participants who identify as URM into DA-JEDI. In Specific Aim 2 we
will provide individualized didactic and experiential skills training through ASN initiatives, through the participants
CTSA, or though DA-JEDI’s own CTSA links. This will include an annual DA-JEDI Symposium. In Specific Aim
3, we will foster unique multi-faceted mentorship opportunities, and finally in Specific Aim 4 we will focus on the
creation of an alumni network, promote networking opportunities and develop an interactive evaluation process
with a strong feedback loop.
Putting it all together, we strongly believe that growing our DA-JEDI participants into future leaders for ASN, the
kidney community, and the DA community, will allow us to better serve our patients, who deserve justice, equity,
diversity, and inclusion in both DA and kidney care.

Public health relevance
NARRATIVE Dialysis access is the Lifeline for dialysis but is unfortunately characterized by significant inequities and disparities in care. We plan to address this problem by recruiting, training (both in dialysis access and professional career development) and mentoring, a group of minority and under-represented in medicine, senior fellows/early career faculty, who will then work within ASN, and their own professional career pathways to address this issue.